Development of GenomeBuild as a Universal Method to Synthesize Genomes

Project Summary
Development of GenomeBuild as a Universal Method to Synthesize Genomes
Opportunity Number: RFA-HG-20-016
PIs: Christopher L. Warren and Mary S. Ozers
Synthetic biology encompasses the ability to de novo synthesize and assemble large oligonucleotides into
genomes of whole organisms, with a broad range of applications in medicine, therapeutics, environmental
sciences, and human genomics. However, the ability to realize the full potential of synthetic biology has been
hampered by the time and cost limitations of building synthetic genomes and large mammalian chromosomes
using current techniques. Additionally, there is no cost effective method to introduce extensive genetic edits
into genomes. The “Design-Build-Test-Learn-Repeat” approach is fundamental to synthetic biology but the
inability to “Build” quickly or cost-effectively inhibits our ability to “Learn,” much less “Repeat.” Furthermore,
with affordability, a diverse array of researchers can be included in this process, not only the most highly
funded laboratories and companies, to propel the field forward and maximize its gains. The ability to custom-
design an entire genome cannot be done with current genomic editing techniques such as CRISPR, and solid-
state synthesis methods on the genome scale are too expensive. In this proposal, we detail a novel method,
GenomeBuild, to inexpensively and rapidly synthesize a high fidelity and completely customizable viral
genome from a standard DNA microarray. As proof-of-principle, we will synthesize a modified form of the 150
kb HSV-1 genome that reproduces the genetic alterations designed in talimogene laherparepvec (TVEC).
TVEC, marketed under the brand name Imlygic™, is the first FDA approved oncolytic virus used for the
treatment of advanced melanoma. Although DNA microarrays can serve as a direct and inexpensive source for
a complex library of oligonucleotides, their high error-rate relative to solid phase synthesis have precluded their
effective use in synthetic biology. Our technology will circumvent this problem by harnessing an unprecedented
high-density peptide nucleic acid (PNA) array to remove imperfect DNA sequences obtained from a
corresponding DNA microarray. Our aims will synthesize high-fidelity microarray-extracted genomic
oligonucleotides that can be assembled into a modified viral genome with less than one error per 75 kb of
sequence on average. Finally, this custom genome will be introduced into a cell line using standard protocols
and assessed for infectivity as compared to a genetically equivalent non-synthesized virus. The inexpensive
cost and fast turnaround time of our GenomeBuild platform will allow production of >100 kb synthetic
oligonucleotides at a significant time and cost savings compared to commercially available products. Upon
successful development, the GenomeBuild technology can be extrapolated from these efforts to additional
organisms such as other viruses and bacteria with larger genomic sizes, making synthetic biology of whole
genomes, and human chromosomes, more attainable for any laboratory.

Public health relevance
Project Narrative / Relevance Development of GenomeBuild as a Universal Method to Synthesize Genomes Opportunity Number: RFA-HG-20-016 PIs: Christopher L. Warren and Mary S. Ozers Synthetic biology holds significant promise in such areas as understanding the role of polymorphisms in human genetics and the development of therapeutic organisms, but has been greatly limited by the inability to quickly design, build, and test custom genomes. Our proposed GenomeBuild technology will significantly improve error-rates in double-stranded DNA synthesis compared to commercially available methods, permitting the synthesis of large DNA fragments (>100 kb in this Phase I). If successful, GenomeBuild will be immediately commercialized at the completion of this grant to allow researchers to order entire custom-designed genomes de novo, simultaneously introduce multiple genetic edits into existing genomes, or simply order very long error- free double-stranded DNA at a fraction of the cost as current commercial providers with a two week turnaround time.